Mechanisms of B cell responses to particulate antigens

PROJECT SUMMARY
Mechanisms of B cell responses to particulate antigens
Two biophysical attributes shared by most animal viruses are the display of viral-specific proteins at certain
densities on the surface of individual virions and the encapsulation of viral genome inside the virion. A threshold
density of viral surface proteins is important to ensure efficient viral infection of host cells. From the perspective
of the host, a threshold density of viral surface proteins may also be critical for the recognition by germline B
cells for efficient mounting of humoral responses. The encapsulated genetic material may also stimulate B cells
through the Toll-like receptors. Substantial mechanistic studies at the single-molecule level and imaging of live
cells have revealed the sensitivity of B cells to the density of antigens. However, at the mechanistic level, it
remains largely uncharacterized how B cells may recognize and respond to the individual as well as collective
attributes of a virus, including the spatial density of proteins and the internal nucleic acids. This project aims to
unravel the cellular and molecular mechanisms of B cell responses to viral features both in vivo and in vitro,
using a new generation of model particulate antigens that we have recently developed. The success of this
project will yield new and important mechanistic information on how B cells recognize particulate antigens similar
to viruses, and reveal the functional outcomes of B cells in response to the recognition of the biophysical features
of these antigens.

Public health relevance
PROJECT NARRATIVE To understand the molecular and cellular mechanisms how protective immune responses are elicited by invading pathogens or vaccines would be useful for the design of vaccines. This project aims to study mechanisms of B cell responses to particulate antigens, or mock viral particles, at molecular and cellular level. The successful completion of this project will fill in a gap in our knowledge regarding how B cells may be activated by viral pathogens.